Systemic Bone Loss Following Fracture in Humans

Project Summary/Abstract:
The most reliable predictor of fracture risk is a previous fracture at any skeletal site. The etiology of this
relationship is not fully known, but one contributing mechanism is that fracture initiates a systemic bone loss
response, which increases future fracture risk at all skeletal sites. Our lab has generated multiple preclinical
studies characterizing this systemic bone loss response following femur fracture in mice. However, the time
course and magnitude of systemic bone loss and recovery in humans has not been investigated, and it is
currently unknown if systemic bone loss differentially affects older people compared to young people. To address
these knowledge gaps, we will use both standard clinical and cutting-edge high-resolution imaging to
characterize the systemic bone loss response following a humerus fracture in human subjects. We hypothesize
that post-fracture systemic bone loss: 1) will persist for 6 months or more after a humerus fracture followed by
partial recovery, 2) will have a greater effect on trabecular bone than on cortical bone, and 3) will have delayed
and diminished recovery in older subjects relative to younger subjects. To investigate these hypotheses, we will
first determine the time course and magnitude of systemic bone mineral density (BMD) loss and recovery
following humerus fracture in young (20-40 years old) and old (60-80 years old) human patients at axial and
appendicular skeletal sites (lumbar spine, bilateral hips, tibiae, and forearms) at baseline, 3, 6, 18, and 36 months
post-fracture and compare these patients to non-fractured control subjects. At each time point we will also
investigate mechanisms of systemic bone loss by measuring serum biomarkers of bone remodeling and
inflammation and tracking patient physical activity using accelerometers. Next, we will determine microstructural
and biomechanical changes in the trabecular and cortical compartments during systemic bone loss and recovery
following fracture in the same patients and how these differ by age. Using clinical quantitative computed
tomography (QCT) and high-resolution peripheral QCT (HR-pQCT) at the ipsilateral and contralateral proximal
femur, tibia, and radius, we will measure trabecular and cortical density and microstructure and use finite element
analysis to estimate mechanical properties of bone. Altogether, these novel studies will reveal that systemic
bone loss and recovery following fracture: 1) occurs in human patients similar to what we have shown in mice,
but on a much longer timeline, 2) has differential effects at axial vs. appendicular skeletal sites and in trabecular
vs. cortical bone, and 3) affects older people differently than younger people, potentially leaving older subjects
with permanent deficits in bone mass and strength. The findings from these studies may ultimately help us
identify mechanisms of systemic bone loss following fracture, and will inform therapeutic strategies and establish
windows of opportunity for preserving skeletal health of patients after a fracture.

Public health relevance
PROJECT NARRATIVE: A previous fracture is one of the best predictors of future fracture risk, but the causes of this relationship are unclear. Systemic bone loss following a fracture is an understudied process that may contribute to a decrease in bone strength and increase fracture risk at all skeletal sites. In the proposed studies we will investigate systemic bone loss following an upper arm fracture in human subjects, determine how this injury response is different in older people vs. younger people, and explore potential mechanisms driving this process.